Training Program in Molecular Medicine

PROJECT SUMMARY
In 2006 Yale started the innovative Medical Research Scholars Program (MRSP) with the mission of
providing broad and deep Ph.D. training in the core basic science concepts of molecular biology, cell biology,
biochemistry, genetics, physiology, pharmacology, and pathology, integrated with intensive exposure to
medically oriented coursework and mentored clinical experiences designed specifically for Ph.D. students. The
ultimate goal of this training is to prepare our students to be future interdisciplinary leaders in the biomedical
sciences, with a unique ability to pursue clinically relevant fundamental basic science inquiry aimed at
elucidating the molecular mechanisms of disease. Until the award of the first five years of NIGMS T32 support
that we are now seeking to renew, MRSP had been supported by a combination of institutional funds and funds
provided by the Howard Hughes Medical Institute (HHMI). Termination of HHMI support after the 2013-2014
academic year, and the desire to continue this highly successful ongoing program constituted the rationale for
applying for the first five-year award of this Molecular Medicine (MM) Training Grant, which supported four
trainee slots per year. Yale University supports all first-year PhD students in the biomedical sciences, and thus
this T32 supports two second-year and two thrid-year students each year. MRSP students participate in a
variety of program activities designed to engage Ph.D. students in medically relevant training and experiences
throughout their graduate studies. The classes focus first on normal human physiology, organ-based cell
biology, and biostatistics, followed by human pathobiology and an introduction to drug discovery, validation,
and clinical trials. MRSP students also have the option to participate with first-year Yale MD students in
weekly small-group physiology “case conference” tutorials, in which they explore in depth the physiological
underpinnings of particular disease states. The cornerstone of the MRSP is a two-year mentored clinical
experience that provides students with in-depth exposure to the science behind human diseases and first-hand
longitudinal encounters with patients to contextualize the mechanistic basis of disease in a way that is not
possible through traditional classroom learning. In addition to these formal activities, the MRSP also provides
ongoing mentoring to all MRSP trainees regarding selection of a thesis research laboratory and assembly of the
dissertation committee to support the goal of the NIGMS Molecular Medicine program to provide training in
the basic biomedical sciences with a focus on elucidating the mechanisms of human disease. Based on the great
demand for admission into the MRSP by outstanding training-grant-eligible students already admitted to
Yale's umbrella biomedical sciences PhD program, we are requesting an increase in the number of annual slots
from four to six, which would allow us to support three second-year and three third-year students each year.

Public health relevance
PROJECT NARRATIVE The past 40 years of biomedical research have witnessed an explosion of cellular, molecular, genetic, and biochemical methods, with these basic science approaches providing massive amounts of information about the biological functions of particular molecular and cellular entities. However, understanding how each of these molecular and cellular entities participate--both separately and together--in the complex systems that comprise the intact organism has lagged behind. Even more importantly, now that basic understanding of these biological principles has advanced so far, it has become crucial to develop more sophisticated clinical and translational approaches for leveraging this information toward the goal of understanding the molecular mechanisms of disease and developing therapeutics.